Metabolism and Endocrinology Core

The main objective of the Metabolism and Endocrinology Core is to provide the expertise, technical resources, and instrumentation necessary to characterize perturbations in metabolism in murine models potentially useful for understanding diabetes, its complications, obesity, and related metabolic disorders. The core will conduct in vivo and in vitro metabolic procedures and offer an extensive list of assays of metabolic substrates, endocrine hormones, and indices of renal function, inflammation and oxidative stress. In addition, the Metabolism and Endocrinology Core will provide assay management services for the analysis of samples generated by all cores.

Public health relevance
Mouse models of diabetes, diabetic complications, obesity and other related disorders have been invaluable for elucidating the disease potential, pathogenesis and treatment of these conditions in the human population. The Metabolism and Endocrinology Core will conduct procedures and analyses on mouse lines submitted to the MMPC-UCD in order to identify potential mouse models of human disease for study.